DEEP BRAIN STIMULATION--THERAPY OF PARKINSON'S DISEASE

The primary purpose of this study is to demonstrate the safety, reliability, and effectiveness of electrical stimulation for the treatment of symptoms of Parkinson's disease.